Targeting ribosome biogenesis and desmoplastic tumor microenvironment for the treatment of advanced pancreatic cancer

Pancreatic cancer (PanCa) treatment is exceptionally difficult due to the extremely poor response to available
therapeutic options. This poor response is mainly due to dysregulation of ribosome biogenesis and desmoplastic
pancreatic tumor microenvironment. The main objective of this SC1 proposal is to establish a rationale based
novel therapeutic regimen for the treatment of advanced stage pancreatic cancer (PanCa). This novel therapy
will provide therapeutic benefit and circumvent chemoresistance via simultaneous targeting of ribosome
biogenesis by RNA polymerase I inhibitor (BMH-21) and desmoplastic tumor microenvironment with hyaluronan
inhibitor (4-Methylumbelliferone). The ribosome biogenesis is the complex and highly coordinated cellular
process leading to the production of ribosomes. This process is aberrantly operated during the development of
cancer, including PanCa and also involved in chemoresistance to therapeutic drugs, such as including
gemcitabine. Hyaluronan (Hyaluronic acid) is one of the major components of the extracellular matrix secreted
by fibroblasts and pancreatic stellate cells which is involved in the formation of desmoplasia in pancreatic tumors
that prevent drug accessibility in the tumors. Thus, strategically targeting of both ribosome biogenesis and
hyaluronan synthesis will effectively suppress the growth and metastasis of pancreatic tumors. BMH-21 was
recently developed as a potent selective inhibitor of RNA polymerase that has shown potent anti-cancer effect
in pre-clinical studies. Our preliminary results have shown promising anti-cancer and chemosensitization effects
of BMH-21 in PanCa models. 4-Methylumbelliferone (4-MU) is a non-toxic hyaluronic acid synthesis inhibitor
with an anti-cancer property that has never been tested in combination with BMH-21 for PanCa treatment. BMH-
21 demonstrated remarkable tumor growth inhibition in the orthotopic tumor xenograft mouse model when
combined with 4-MU. Based on these compelling evidences, we hypothesize that the combination of BMH-21
and 4-MU proffers a pronounced anti-cancer efficacy due to improved drug uptake into tumors via repression of
desmoplasia and ribosome biogenesis processes. Three specific aims are proposed. In Aim 1, we plan to
investigate underlying molecular mechanisms and functional impact of BMH-21 and 4-MU to inhibit the growth,
metastatic phenotypes, and overcome chemoresistance. In Aim 2, we will investigate whether and how BMH-21
and 4-MU combination inhibits pancreatic tumor growth and metastasis in an orthotopic xenograft mouse model.
Under Aim 3, we will elucidate the therapeutic and chemosensitization efficacy of BMH-21 and 4-MU combination
in a transgenic mouse model (KPC) of PanCa. We will also determine how this combination influences pancreatic
tumor immune surveillance. This study has a high significant translational impact on the clinic as it will establish
a new rationale-based therapy for the treatment of advanced metastatic PanCa in humans. Successful
completion of this SC1 proposal will set a strong foundation for the PI and his research team to further pursue
an NIH competitive grant (i.e. R01 or R21) for future clinically related studies.

Public health relevance
Pancreatic adenocarcinoma shows increased rate of ribosome biogenesis and desmoplastic tumor microenvironment resulting in poor therapeutic response. Thus, novel strategy is required to inhibit ribosome biogenesis and depletion of desmoplastic TME for the management of advanced pancreatic cancer. This study for the first time will establish a new therapeutic approach for the treatment of advanced pancreatic tumor growth via targeting ribosome biogenesis and desmoplastic tumor by combination therapeutic regimen of RNA polymerase I and hyaluronan inhibitor (BMH-21+ 4-Methylumbelliferone).